Genomics, Bioinformatics & Biostatistics, and Microphysiological Systems Core

GENOMICS, BIOINFORMATICS & BIOSTATISTICS, AND MICROPHYSIOLOGICAL SYSTEMS FACILITY
CORE (GBBM-FC) ABSTRACT
It is well established that chemical exposures to biological systems result in expression changes of numerous
RNA and protein molecules and these changes are correlated with, and can be indicative of toxicity. In
addition, many molecular epidemiologic studies have identified correlations between genetic polymorphisms
and the incidence of environmentally-related diseases. Toxicological monitoring increasingly involves the
assessment of genetic and other molecular measurements derived from human individuals and animal models,
to detect markers of disease susceptibility and to identify early indicators of chemical effect. Various targeted
molecular methods as well as genomics, epigenomics, transcriptomics, proteomics and metabolomics
approaches have been developed in recent years and continue to develop rapidly. These methods
complement each other and allow for mechanistic investigations of entire biological pathways and networks, as
well as their individual components. The optimal application of these state-of-the-art methodologies requires
considerable expertise in a) sample preparation and processing, b) generation and quality assessment of the
data, c) rigorous statistical and bioinformatics analysis, d) as well as interpretation of the complex data. Most
investigators do not possess the financial resources or specialized expertise to keep up with the rapid
technological advancements in these areas. However, it is critical for investigators to have access to the latest
technologies in order to be competitive and to perform cutting-edge research. The Core addresses these
challenges by providing access to the necessary expertise in OMICs-based methods that support
environmental health sciences research. The Core also provides access to sophisticated in vitro systems that
mimic complex tissue architecture and provide platforms to investigate organ-like physiology in the context of
toxicological perturbations. The primary goal of the Core is to empower Center affiliates to integrate
state-of-the-art genomics, transcriptomics, epigenomics, proteomics, and metabolomics technologies,
as well as microphysiological in vitro systems into their Environmental Health Sciences research in a
cost-effective manner.